Harnessing Technological Innovation and Community-Engaged Implementation Science to Optimize COVID-19 Testing for Women and Children in Underserved Communities

Center Summary/Abstract
Nonalcoholic fatty liver disease (NAFLD) is escalating in California and the United States and is associated with
the rising obesity epidemic. NAFLD is a hepatic phenotype that encompasses the more serious manifestation of
steatohepatitis (NASH), considered to be a prerequisite for liver cancer (hepatocellular carcinoma/HCC). We
also know from recent clinical studies that chemical toxicant exposure, in the absence of obesity, can lead to
toxicant-associated steatohepatitis (TASH), which closely resembles the pathology of NASH. These findings are
relevant to SRP stakeholders in Region 9, since California ranks high in National Priorities List (Superfund sites)
nationally and contains thousands of additional hazardous waste sites (HWS). In addition, the UCSD NAFLD
Research Center shows that American Indians and Hispanics, combined the largest non-Caucasian population
in California, are at far greater risk of developing NAFLD. Over the past five years, our SRC has leveraged
resources to demonstrate that TASH is greatly accelerated by consumption of high-fat diet (HFD) or after a
diabetic episode in mice. These findings are relevant, since we can speculate that American Indians and
Hispanics are more susceptible to TASH development, a risk amplified by unhealthy diets, poverty and health
disparities. The UCSD SRC will be developing models through its Biomedical projects to characterize the
mechanisms of Superfund toxicant induced TASH development and cancer, while the Environmental Science &
Engineering (ES&E) projects will develop tools for NPL-toxicant detection and remediation. Biomedical and
ES&E projects will be assisted in these efforts by Research Core services that will provide tools for mouse
genetic production, metabolomic and sophisticated Bioinformatic analysis. A key objective of the projects is to
highlight scientific findings to maximize Research Translation, which will happen with collaborations between the
projects and the Research Translation Core. We believe our program is innovative and paradigm shifting, since
it has the potential of linking important basic research findings regarding Superfund toxicant exposure with
human disease biomarker identification through collaborations with the UCSD NAFLD Research Center, which
contains one of the largest NALFD cohort studies in the world. Importantly, our Biomedical findings and tools
developed in the ES&E projects will be used as resources and knowledge gained to reduce cumulative impacts
and health disparities. These initiatives will be leveraged through Community Engagement Core efforts in
disadvantaged Hispanic neighborhoods in San Diego and Mexico where statistics confirms that obesity is an
escalating problem both in children and adults. Since the incidence of NAFLD and liver cirrhosis is on the rise in
both children and adults and may be linked to toxicant chemical exposure, our findings will be communicated to
SRP primary stakeholders at the U.S. Environmental Protection Agency and the Agency for Toxic Substances
and Disease Registry, in addition to state and local agencies.

Public health relevance
Center Narrative Of key importance to the Superfund Research Program (SRP) and SRP’s primary stakeholders is the link between nutrition, health disparities and environmental toxicant exposure toward the development of fatty liver disease, steatohepatitis, cirrhosis and liver cancer. Work conducted at the UCSD SRP Center is dedicated towards understanding the mechanisms associated with toxicant-induced steatohepatitis (TASH) and cancer, which may be an escalating problem in many susceptible Hispanic and American Indian communities that are exposed to household, occupational and industrial chemical exposure. Our efforts will provide important findings linking mechanisms of TASH and cancer with disease prognosis, which can be communicated to impacted communities to serve as intervention tools to assist in prevention of toxicant exposure.